CONTINUOUS, PULSATILE, AND SINGLE DOSE GH ADMINISTRATION IN GH-DEFICIENT ADULTS

The metabolic effects of GH in man are differentially affected by either the pattern of GH delivery or by the circulating GH concentration. COMPUTER ONLY.